EFFECTS OF INHALED FLUTICASONE PROPIONATE, ROTADISK, OR AIROBID ORAL INHALER

The objective of this study is to compare the effects of fluticasone propionate, Aerobid and placebo on the HPA axis. This comparison will be made using the following tests: basal AM plasma cortisol and serial plasma cortisol levels following Cortrosyn stimulation.